MANUFACTURING PROCESS DEVELOPMENT OF 4-HB

The overall objective of this project is for the contractor to support the chemistry, manufacturing, and
controls (CMC) development of 4-HB.

The objectives of this study are:
1. The contractor shall develop a manufacturing process for 4-hydroxybenzoic acid (4-HB) based on the
suggested scheme (1,2, and 3) and develop a cost and operation-efficient process for generating GMP
batch 4-HB.
2. The contractor shall perform analytical development to release 4-HB and detect all related impurities.
3. The contractor shall perform a long-term stability study on 4-HB.